EPIDEMIOLOGY OF CEREBROVASCULAR DISEASE IN ADULTS

This investigation is aimed 1) at evaluating the effect of heart disease and hypertension as potentially treatable precursors of completed stroke and transient ischemic attacks; 2) at documenting unusual patterns of cerebrovascular disease; 3) at determining the autopsy patterns for patients dying with cerebrovascular disease in defined community; and 4) at examining if weather parameters have any effect on stroke incidence.